Administrative Core

The overall goal of this proposal is to establish a regional mental health network or

Public health relevance
RELEVANCE (See instmctions): We propose an HLA that aims to develop a sustainable body of research in Latin America that improves task-shifting strategies to facilitate community health care for persons with severe mental disorders. The Administrative Core aims to bring together investigators across the Americas working on this HLA in a way that maximizes interaction, and builds the necessary infrastructure, that ensures that the aims of this work can be achieved.